Aligning facility leadership and climate to advance mental health services integration in Malawi

ABSTRACT
Task-shared mental health interventions are effective in low- and middle-income countries, yet they remain
underutilized and the mental health treatment gap remains substantial. Innovative implementation strategies
are needed to successfully integrate evidence-based mental health treatments into medical care in LMICs.
A common component of many implementation efforts is a “champion” strategy which identifies and
empowers an on-the-ground staff member as the implementation champion, in charge of focusing their
colleagues’ efforts on implementation of the evidence-based treatment model. Yet a growing body of research,
including our own work in Malawi and elsewhere, highlights that the champion’s success is strongly influenced
by the strength of support from their line manager and other up-the-chain organization leaders, who are critical
in aligning the organization’s climate and priorities in support of the implementation effort.
Approaches to influencing leadership engagement to change organizational climate and align priorities has
been developed over decades in the field of organizational and industrial psychology but only relatively
recently applied to implementation science health research and primarily to implementation in high-income
countries. The Leadership and Organizational Change for Implementation (LOCI) is a recently developed
multi-level leadership coaching implementation strategy that has demonstrated effectiveness in changing
organizational climate, aligning priorities, and enhancing mental health treatment model integration in the US
and Norway, but has not been adapted to or tested in low-income country settings. LOCI has significant
potential to address the gaps identified in our current research by aligning leadership priorities to support
champions in advancing mental health integration.
The objective of the present proposal is to test the impact and sustainability of supplementing the standard
champion implementation approach with the LOCI leadership alignment strategy to achieve successful
integration of an evidence-based, task-shared mental health treatment model into general medical care. We
will use a cluster-randomized trial to evaluate the impact of the adapted leadership alignment strategy on
integration of an evidence-based mental health treatment package into multiple medical care settings (NCD,
HIV, and TB care), assessing proximal (climate), primary implementation (adoption, reach, fidelity),
downstream patient mental health, and cost-effectiveness outcomes as well as sustainability after conclusion
of the leadership alignment activities. Additionally, we will use the structure of the research project to further
strengthen capacity among mental health researchers and policy makers in Malawi.
Leadership alignment strategies are an understudied but essential ingredient for successful mental health
integration efforts. This project will make a major contribution to our understanding of the role of leadership
alignment in advancing evidence-based mental health integration in LMICs.

Public health relevance
PROJECT NARRATIVE The overall objective of this proposal is to test, using a cluster-randomized RCT, the impact and sustainability of a health system leadership alignment strategy to achieve successful integration of an evidence-based, task-shared mental health treatment model into general medical care in Malawi. Leadership alignment is an essential ingredient for successful mental health integration but has received extremely limited attention in low and middle income countries. This project will make a major contribution to our understanding of the role of leadership alignment in advancing evidence-based mental health integration.